IGF::OT::IGF Event titled "Precision Medicine and Hispanic Health: Contributions to Reducing Health Disparities"

Logistical support for event titled Precision Medicine and Hispanic Health: Contributions to Reducing Health Disparities.